Sensory and learning improvements elicited by oscillatory coupling through local and long-range interneurons

Project Summary
My long-term goal is to become a successfully funded, independent neurobiologist, conducting research aimed
at improving our understanding of learning and memory. This goal will be accomplished by the implementation
of a highly coordinated, thorough, and integrated career development plan including components of mentored
guidance and training, an adept research environment, and a complementary research project. First, a career
development plan comprised of a mentor, and co mentors, courses and conferences has been established to
provide the applicant with the skills and guidance to transition into a position of independence. The mentor, Dr.
Diego Restrepo, is a successfully funded researcher and leading expert in neuroscience and the co-mentor,
Dr. Jamie Peters, is a recognized leader in neural circuits controlling learned behaviors, primarily those
controlling drug seeking and fear in which the prefrontal cortex plays an essential role. They are well suited to
oversee my training. The mentoring team will provide critical guidance and feedback on aspects of career
development and technical components high density electrode recording with Neuropixels, data analysis, and
olfactory behavior tasks. The mentoring committee includes members at different levels of their career ranging
from young to senior faculty who will specifically assist the applicant in components directly related to career
transition. In addition, courses in MATLAB, python and conferences on neuroscience are included to facilitate
these components of the training program. Second, an adept research environment – the Department of Cell
and Developmental Biology at the University of Colorado, along with associated resources, core facilities, and
faculty members not directly involved in the applicant’s advisory committee – is established to provide
assurance of the applicant’s success. Third, a research project has been proposed to facilitate my training in
exciting new areas essential for my path to independence while simultaneously maintaining the key goals of
studying neuronal signaling networks as related to learning and memory. The research tests the important
hypothesis that altering local and long-range interneuron coupling and CaMKIIα-mediated plasticity
mediate changes in PAC that result in an increase in odor elicited change in high gamma phase
reference power and an increase in accuracy for decoding odorant identity during learning in the go-no
go task. Aim 1 will evaluate Closed loop optogenetic stimulation of local PV or SST interneurons or long-range
interneurons targeting hippocampus or mPFC in the peak or through of theta will cause coherence of
oscillatory coupling causing the mice to increase decoding accuracy. Aim 2 will evaluate transient disruption of
CaMKIIα expression in local SST interneurons or long-range interneurons targeting mPFC causes a change in
the transmission of information from the CA1 to mPFC disrupting the ability of these mice to learn to
discriminate odorants. Collectively, this comprehensive career development and research plan will ensure my
successful transition from a dependent research position into one of well-prepared independence.

Public health relevance
Project Narrative The ability to learn and form memories is crucial for everyday life. Therefore, it is not surprising that diseases that affect these abilities are devastating and individuals affected are often unable to care for themselves. The fundamental goal of this project is to understand the role of local and long-range interneurons in hippocampal and medial prefrontal cortex oscillations in associative learning.